In Vitro and Animal Models for Emerging Infectious Diseases and Biodefense

This IAA provides for the development and standardization of small animal models, and may include efficacy testing of vaccines and/or therapeutics, including GLP studies to support product licensure. Vaccines/therapeutics which are efficacious in small animals may be further tested in non-human primate models.